Proteasome activation to protect the white matter in neonatal hypoxic-ischemic encephalopathy.

Neonatal hypoxic-ischemic encephalopathy (HIE) from birth asphyxia causes persistent and severe neurologic
disabilities, even in patients who receive therapeutic hypothermia. We found in clinical studies that white matter injury
on MRI persists after hypothermic treatment. Thus, hypothermia is not fully protective. White matter injury is a prominent
yet understudied component of the neurologic disabilities observed in neonates who receive hypothermia for HIE.
Therapeutic adjuncts that protect the white matter might reduce the risk of permanent neurologic injury in HIE.
Hypoxia-ischemia (HI) in neonatal pig, which has human-like white matter tracts, produces brain damage similar to
that of full-term human newborns with HIE, including the white matter injuries observed in clinical studies. Our model
includes clinically relevant whole-body hypothermia, rewarming at 0.5°C/h, sedation, continuous hemodynamic
monitoring, ventilator support, and correction of blood gas and electrolyte abnormalities to mimic clinical neonatal
intensive care. Preliminary data suggest that insufficient proteasome function mediates persistent white matter injury
after HI and hypothermia. We postulate that white matter proteasome insufficiency causes a failure to clear oxidatively
damaged proteins, causing oligodendrocyte apoptosis, potential disruption of oligodendrocyte precursor maturation,
myelin and axonal injury, and white matter volume loss after HI and hypothermia.
We will elucidate the proteasome’s role in white matter injury after whole-body HI and overnight hypothermia in
neonatal swine. White matter injury and oligodendrocyte biology will be studied with neuropathology (including
oligodendrocyte precursor maturation, stereology, cell death, and electron microscopy) and biochemistry (including
protein post-translational modification and proteasome composition and activity) through 1 month recovery after HI. T-
maze neurocognitive behavior testing with neuropathology correlation will provide a functional outcome. We developed
new methods to genetically modulate proteasome activity in distinct, targeted regions of white matter in neonatal pig
forebrain using virus-mediated enforced expression of a proteasome activator subunit or proteasome inhibition with
short hairpin small interfering RNA. We will also use a small molecule proteasome inhibitor to determine whether
proteasome inhibition aggravates white matter injury. Moreover, we will test the potential of the drug oleuropein to protect
white matter. Oleuropein is a readily bioavailable compound with proteasome activating properties and few clinical side
effects. An intravenous oleuropein dosing regimen will be used that protects oligodendrocytes and myelin, increases
proteasome expression, and promotes clearance of oxidized proteins after HI and hypothermia. We will identify whether
oleuropein acts on the standard proteasome or the immunoproteasome. Cultured human oligodendrocyte experiments
will validate the proteasome as a therapeutic target and oleuropein’s actions after oxygen glucose deprivation. This
project will advance the neonatal HI and cell biology fields by investigating novel mechanisms by which proteasome
insufficiency mediates hypothermia-resistant injury in white matter. We will discover whether proteasome activation is a
relevant therapeutic adjunct to hypothermia to protect white matter and improve neurologic outcomes in HIE.

Public health relevance
PROJECT NARRATIVE Babies suffer severe and permanent neurologic disabilities from brain white matter injury after birth asphyxia despite clinical cooling. We will determine whether: 1) impaired protein quality control contributes to the white matter injury, 2) increasing clearance of the damaged proteins protects the white matter, and 3) a drug derived from olive leaves restores the normal physiologic process for removing damaged proteins. This project’s goal is to improve health and neurologic outcomes in babies with brain injury.